2021 Pediatric Dermatology Research Alliance (PeDRA) Annual Conference

PROJECT SUMMARY Pediatric dermatology is a relatively young specialty that has lacked robust data about the natural history and long-term outcomes of skin disorders that begin in infancy and childhood. In addition, evidence-based guidelines of care, standardized treatment protocols, and FDA approved therapies for the majority of pediatric dermatologic disorders are sparse. The Pediatric Dermatology Research Alliance (PeDRA) was founded in 2012 to address these crucial yet unmet needs. PeDRA's primary mission is to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease. The long-term goal of PeDRA is to leverage such research to improve the health outcomes of children with skin disorders. Annual conferences have been integral to the success of PeDRA, providing a forum for educating investigators, identifying and prioritizing research needs and opportunities, and developing and initiating innovative projects. A combination of didactic lectures, expert-led interactive discussions, panel and poster sessions, and disease-focused small-group sessions are the foundation of PeDRA's meetings. This proposal is for the 9th PeDRA Annual Conference, set to take place in October of 2021 with the following aims: 1) Provide education to pediatric dermatology investigators on engagement with a broad and diverse group of collaborators; 2) Advance existing research projects and develop new research priorities within PeDRA's focus areas; and 3) Provide a forum for the dissemination of final and ongoing research results from a broad group of investigators to a diverse audience that includes patient stakeholders, industry representatives, and researchers from multiple fields. The expected outcome of this meeting will be valuable interactions and partnerships that will enhance the productivity of researchers in pediatric dermatology and lead to the conduct of impactful, high-quality studies. These activities will accelerate the pace of pediatric dermatology research, allowing clinicians to better understand, prevent and treat skin disease in children, and giving patients and families options to manage disease and make informed treatment decisions.

Public health relevance
PROJECT NARRATIVE Established in 2012, the Pediatric Dermatology Research Alliance (PeDRA) is a nonprofit research organization driven by the mission to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease, and the PeDRA Annual Conference has been integral to the organization's growth and success since the first conference in 2013. In 2021, the conference will continue PeDRA's work to educate and empower physician scientists and other stakeholders in the field through and agenda that disseminates research results, supports the identification of new research initiatives, and drives ongoing collaborative studies forward under the theme of “Building Bridges”. The conference will accelerate the pace of pediatric dermatology research in pursuit of PeDRA's vision of changing lives and healing children with skin disease through collaboration and discovery.